Mechanisms of trace amine-associated receptor gene choice

Project Summary
Monoallelic expression, the preferential activation of either the maternal or paternal allele of a given gene,
plays key roles in myriad biological processes including dosage compensation, cell-type specification,
phenotypic variation and disease pathogenesis. Olfactory receptor genes in mammals exhibit an intriguing
form of random monoallelic expression—olfactory sensory neurons in the nose choose to express a single
allele of a single receptor gene from a repertoire of over 2,000 alleles. Despite significant progress in recent
years, the mechanisms underlying olfactory singular expression remain unclear. Current models for how this
process occurs have come from studying the large family of Odorant Receptors (ORs). The Trace Amine
Associated Receptors (TAARs) constitute a much smaller receptor gene family that is also subject to
monoallelic expression. However, the mechanisms underlying TAAR gene choice remains unknown.
The broad goal of this project is to shed light on the core mechanisms that are required to produce
olfactory monoallelic expression by identifying the commonalities and differences between TAAR and OR gene
regulation. Our ongoing work has identified the specific developmental lineage of sensory neurons that
preferentially choose TAAR genes, all of the genetic elements (enhancers) in the TAAR gene cluster that are
required for expression, and several new transcriptional regulators that may play a role in selective TAAR
expression. The Aims of the proposal are 1) to identify the functionally active sequence motifs in the TAAR
enhancers that drive monoallelic expression, 2) to define how key transcription factors regulate TAAR gene
choice, and 3) to determine whether and how TAAR gene expression is regulated by the three-dimensional
chromatin landscape and potential interactions with OR gene enhancer networks. These experiments combine
powerful genetic models and epigenetic assays to test and extend current models of mammalian monoallelic
gene expression.

Public health relevance
Project Narrative The goal of this project is to elucidate the molecular and genetic mechanisms underlying random monoallelic gene expression of olfactory receptor genes in mammals. The experiments will shed light on genetic mechanisms that play a central role in defining the vast array of cell types that make up the mammalian brain, and that influence development, phenotypic variation, and disease.